Novel Diurnal Model for In Vitro Fertilization Studies

Project Summary
Light plays a vital role in regulating physiological processes and influences female reproductive success through
the circadian system. However, most modern Americans live the majority of their lives indoors where electrical
lighting is lower quality than natural light, resulting in exposure to lower intensities of light for an extended duration
past sunset, compared to outdoor lighting. Increased reproductive disorders found in nighttime shift workers and
seasonal reductions in assisted reproductive technology (ART) success provide compelling evidence that light
quality is linked with female fertility. Light exposure comprises various qualities, including photoperiod and
intensity, which play a role in resetting circadian rhythms. Although light affects ovarian function in both humans
and nocturnal rodents, it remains unclear how these light properties contribute to female reproductive success.
Additionally, trace elements (TE), such as zinc, are essential for follicle development, fertilization, and IVF
success. Serum TE exhibit circadian variations in humans and nocturnal rats, but the impact of light and circadian
variations on TE and female fertility is not well understood. Most research on photic and TE mechanisms that
control fertility relies on nocturnal rodents; however, given the opposing in timing in hormone release, ovulation,
light responses, and circadian TE levels between nocturnal and diurnal species, this approach leaves a critical
gap in our ability to understand how light influences fertility in diurnal species, including humans. I will address
this gap by using a diurnal rodent model, the Nile grass rat, to investigate how the hypothalamic-pituitary-ovarian
axis adapts to changes in light quality. My preliminary data show that light quality modulates reproduction in
grass rats, where long and bright days (LD14:10, 1000 Lux) reduce time to first litter in grass rats compared to
standard conditions (LD12:12, 300 Lux). I also show that state-of-the-art laser ablation time-of-flight mass
spectrometry (LC-TOF-MS) can be used to generate quantitative maps of TE in the ovary and hypothalamus.
These data, coupled with work from my Co-Sponsor validating grass rat superovulation and embryo culture,
place me in an excellent position to complete the proposed studies. This proposal will determine how light quality
impacts oocyte quality and IVF success (Aim 1), the relationships between circulating TE and ovarian responses
in the context of circadian and photic adaptations (Aim 2) and how hypothalamic-pituitary pathways guiding
reproduction adapt to light quality (Aim 3). I hypothesize that light quality produces adaptations in hypothalamic
circuits guiding female fertility, altering TE distribution, in turn modulating ovarian function and IVF success.
These studies will establish a novel diurnal rodent model to provide key insights into the neuroendocrine
mechanisms by which light qualities modulate female fertility. The training from this proposal, with guidance from
my Co-Sponsors and mentoring committee, will prepare me for the transition to a successful career as an
independent academic researcher investigating the role of light and TE in reproductive success.

Public health relevance
Project Narrative The majority of modern women are exposed to reduced light quality from extended time spent indoors, employment requiring nighttime work, and nighttime technology use, leading to numerous health risks, including reproductive deficits. This basic science proposal will validate a diurnal rodent model to elucidate both individual and combined contributions of photoperiod- and light intensity-driven adaptations in the female reproductive axis. This work will determine the impact of light quality on trace element and neuroendocrine mechanisms modulating fertility and in vitro fertilization success.